Graduate Training Program in Quantitative and Chemical Biology at Indiana University Bloomington

Abstract
Thirty-two collaborative training faculty from the Departments of Chemistry, Biology and Molecular and
Cellular Biochemistry, and interdepartmental programs in Cell, Molecular and Cancer Biology (CMCB) and
Neuroscience, request funding to renew our predoctoral training program at the chemistry-biology interface
(CBI) in Quantitative and Chemical Biology (QCB) at Indiana University, Bloomington. Our training mission is
to transform graduate education in the molecular sciences on our campus by facilitating interdisciplinary and
collaborative research training in the chemical and biological sciences to address important problems in
biology and medicine. We outline an evolving, innovative and forward-looking program that takes our trainees
from mere technical proficiency in their chosen disciplines to the development of critical thinking skills across
disciplinary boundaries and professional communication and leadership skills that will allow our trainees to
thrive in the next stage of their careers. We couple a core didactic curriculum in chemical and physical biology
through two 1.5 credit core courses, Introduction to Quantitative Biology and Measurement (CHEM C680)
and Introduction to Chemical Biology I (CHEM C681) and QCB Journal Club (CHEM C689) to a topical
collection of extracurricular programmatic elements that are organized nearly exclusively by QCB trainees
under the leadership of two rotating QCB ambassadors. These programmatical activities include QCB
Student-invited Seminar Series and QCB Evenings, a “super-group” research seminar series, and the annual
Watanabe Symposium in Chemical Biology, which brings diverse scientists to Bloomington from academia
and industry to network with QCB trainees. Innovative programmatic elements include a trainee-run off-
campus retreat and an e-learning/”flipped” classroom instructional approach used to bring prospective
trainees “up to speed” on core didactic material and to significantly augment Plans for the Instruction in
Methods for Enhancing Reproducibility and the Responsible Conduct of Research. We also outline an
internship program for third year trainees to help prepare them for a wide range of career paths after
graduation. The program is directed by a Program Director and a Co-Program Director, each with
complementary expertise in physical and chemical biology, and is overseen by a Steering Committee that
includes preceptors from all five participating departments and programs. The Recruitment Committee is
charged with all aspects of identifying and recruiting training grant-eligible students for support by the program
in training years 2 and 3 or year 3 only. Our program enjoys strong financial support from the College of Arts
and Sciences and the University Graduate School who have committed fifteen (15) matching slots over the
five-year project period and significant matching funds for programmatic elements. Comprehensive diversity
recruitment and trainee retention plans are provided which will allow us to continue our efforts to maintain a
strong, diverse and inclusive trainee cohort.

Public health relevance
Project Narrative Indiana University, Bloomington proposes to continue its development of a predoctoral training program at the Chemistry-Biology Interface named the Quantitative and Chemical Biology (QCB) Training Program. Faculty trainers from the Departments of Chemistry, Biology and Molecular and Cellular Biochemistry and interdepartmental programs in Cell, Molecular and Cancer Biology (CMCB) and Neuroscience seek to continue to provide topical interdisciplinary instructional and career development opportunities in an inclusive and supportive environment.